Molecular Mechanisms of Sugar Sensing by Insect Gustatory Receptors

PROJECT SUMMARY
Animals desire sugars for their energy potential and for the pleasurable sensation of tasting sweetness. Despite
the importance of sugar receptors in influencing nutrient sensing, metabolic responses, and taste perception,
few studies have been performed to identify the molecular mechanisms underlying sugar detection and
recognition. The proposed project will address this gap by integrating structural and functional studies to offer a
unique perspective on the biophysical basis for sweet taste. In the first two Aims, we will focus on a single
exemplary GR, Gr9 from the silk moth Bombyx mori, and couple structural methods with mutagenesis and
functional assays to understand why it can only be activated by a single type of sugar, D-fructose. In Aim 1, we
will investigate how this receptor binds D-fructose, how binding is coupled to the channel gate, and how different
subunits within the tetramer interact cooperatively to open the ion-conducting pore. In Aim 2, we will investigate
why other similarly sized sugars bind but do not activate the channel. In Aim 3, we will expand our analysis to
other GRs that are activated by different sweet compounds to resolve the relationship between receptor
sequence and ligand specificity. Our structural and functional analyses of GRs will provide a crucial foundation
to understand how different tastants are recognized by a diverse collection of receptors and present novel routes
for the design and optimization of small molecules that interfere with the gustatory systems of insect vectors of
human pathogens.

Public health relevance
PROJECT NARRATIVE Insects are vectors for many pathogens that contribute to the deaths of more than a million people each year. Mosquitoes and other biting insects use a variety of gustatory cues to identify their human targets, but the molecular mechanisms underlying insect taste receptors are poorly understood. Here, we propose to elucidate the structure and function of insect taste receptors, thus providing a critical foundation for developing new strategies to limit the human and financial damage caused by insect pests.